Validation of miRAD assay as a biodosimetry tool for radiological/nuclear triage applications in pediatric and geriatric population

PROJECT SUMMARY
There has been a dire need for developing a rapid biodosimetry tool for triaging victims in the aftermath of any
radiological/nuclear mass casualty incident(s). Rapid triage is critical for timely administration of medical
countermeasures and proper allocation of resources, thus saving lives. Currently, there are no US Food and
Drug Administration (FDA) approved tests or assays that allow early exposure categorization of victims for
effective medical countermeasures. The current gold standard for radiation biodosimetry is the dicentric
chromosome assay (DCA) but its application to mass casualty incidents is severely restricted as it requires 48-
72 hours for dose estimation. To provide a rapid absorbed dose estimation within a few hours, we have
developed a highly sensitive test tracking two-microRNAs found in blood samples collected by a simple finger
prick. The miRAD assay enables accurate does estimation in less than four hours, covering dose ranges and
time points critical for medical intervention in victims. In the miRAD assay, radiation dose dependent changes
in evolutionarily and functionally conserved miR150-5p in the blood is internally calibrated with miR23a-3p
which is non-responsive to radiation as it is not expressed at a significant level in blood cells, yet abundant in
blood and passively released into circulation from non-blood cells. Our assay, tested so far in blood samples
from irradiated mice, non-human primates and human radiotherapy patients and has shown a great potential
for development as an effective triage tool. Robustness of the baseline expression of both the responder and
normalizer using blood samples collected by a finger prick has been validated in volunteers, including
individuals afflicted with common chronic medical conditions. The kinetic response of the miRAD assay will
favorably allow integration with other clinical signs (clinical symptoms, time of emesis) and help prioritize
treatment in the “life savable” group. As further development and refinement of the assay for triage applications
is needed, the current proposal is designed to test the accuracy of dose prediction by miRAD with the gold
standard DCA by using an in vivo total body irradiated mouse model system. Since alteration in miR150-5p in
blood after radiation exposure appears to be an intrinsic in vivo phenomenon, we will systematically compare
the miRAD assay with DCA for absorbed dose validation in pediatric and geriatric population mimicking a
heterogeneous human population. The assay has potential utility at different stages in radiological/nuclear
disaster management, including early triage, precision dosimetry, follow-up and evaluation of
countermeasures. Beyond its utility in radiation disaster preparedness and management, the assay will have
utility in evaluation of bone marrow ablation and reconstitution kinetics in radiotherapy patients.

Public health relevance
NARRATIVE This proposal is aimed to evaluate the potential of circulating microRNA based rapid biodosimetry tool for radiological/nuclear mass casualty incidents. The evaluation will be performed through a systematic comparison with the gold standard, dicentric chromosome assay for the dose prediction accuracy of miRNA- 150 based finger stick radiation biodosimetry test in heterogenous population.